Role of the Unfolded Protein Response in Photoreceptor Degeneration

PROJECT SUMMARY
Client proteins of the secretory pathway fold to their native shapes in the endoplasmic reticulum (ER) through
reactions catalyzed by chaperones and other ER protein-modifying enzymes. Under high secretory demand,
these activities are overwhelmed, causing unfolded proteins to accumulate. If uncorrected, such “ER stress”
increases the risk of cell degeneration and death. Photoreceptors, specialized neurons in the retina
responsible for phototransduction, have one of the highest secretory burdens of any human cell, making them
particularly susceptible to ER stress. Recent evidence has implicated pathogenic ER stress as a potential
cause of retinitis pigmentosa (RP), a blinding disease marked by the progressive loss of photoreceptors,
especially in cases due to mutations in rhodopsin that prevents its proper folding.
Accumulation of unfolded proteins in the ER triggers signaling pathways called the unfolded protein response
(UPR). Under remediable levels of ER stress, the adaptive UPR (A-UPR) activates transcriptional and
translational changes that restore homeostasis. However, under irremediably high ER stress, these adaptive
measures fail and the signaling pathways instead trigger programmed cell death—referred to as the terminal
UPR (T-UPR). We discovered that the ER transmembrane protein IRE1, a bifunctional
kinase/endoribonuclease (RNase), converts an A-UPR to a T-UPR. During rectifiable ER stress, IRE1
transiently trans-autophosphorylates, causing its RNase to trigger the A-UPR through frame-shift splicing of the
mRNA encoding XBP1 transcription factor. But under high/chronic ER stress, IRE1's kinase becomes
hyperphosphorylated, causing RNase hyperactivation that leads to massive degradation of ER-localized
mRNA and T-UPR events including: (1) loss of differentiated cell identity, (2) local sterile inflammation, and (3)
programmed cell death through pyroptosis and apoptosis.
We hypothesize that an IRE1-induced switch from an A-UPR to a T-UPR contributes to ER stress-induced
photoreceptor loss. Our overall goal for this R01 is threefold: (1) define the role of IRE1 signaling on normal
photoreceptor health; (2) elucidate key underlying molecular mechanisms through which IRE1 converts an A-
UPR to a T-UPR in photoreceptors; and (3) target IRE1 in photoreceptors using our recently developed
kinase inhibitors for long-term prevention of retinal degeneration. Our research project, to be driven by three
labs with complementary and synergistic skills as well as experienced collaborators, promises to provide
powerful mechanistic insights into the role of the UPR in photoreceptor health and degeneration, and to
establish whether the UPR can be successfully drugged to prevent photoreceptor loss in RP.

Public health relevance
PROJECT NARRATIVE Approximately 100,000 Americans suffer from retinitis pigmentosa (RP), an untreatable blinding disease that results from the premature death of photoreceptors (e.g., rods and cones). We have evidence in animal models of RP that photoreceptors inappropriately activate an internal suicide program, and that stopping this cell suicide program preserves vision. In this proposal, we explore a novel strategy to protect photoreceptors from triggering their internal suicide program, which if successful may lead to new drugs to treat RP and related blinding diseases.